Daily Impact of Sexual Minority Stress on Alcohol-Related Intimate Partner Violence among Bisexual+ Young Adults: A Couples' Daily Diary Study

This study is guided by a long-term goal of optimizing alcohol-related intimate partner violence (IPV; psychological, physical, sexual, and other types of non-heterosexual abuse [e.g., threatening to out a partner]) interventions for bisexual and other multigender-attracted (bi+) young adults and their partners. As a critical first step toward this goal, this R21 will identify modifiable intervention targets for alcohol-related IPV by developing new scientific knowledge of the unique day-to-day processes that potentiate and ameliorate IPV after alcohol use among bi+ young adults and their partners. This study will also explore subpopulations of bi+ young adult couples who should be prioritized in future alcohol-related IPV research.
Alcohol use proximally increases the likelihood of IPV perpetration, particularly among young adults ages 18-25. Relative to those with other sexualities, more bi+ young adults endorse heavy alcohol use and IPV, but research has not identified daily experiences that may potentiate or mitigate alcohol-related IPV within this priority population. This critical scientific gap may be attributed to (1) limited inclusion of bi+ populations in alcohol-related IPV research, with no daily diary studies focusing on bi+ young adults, (2) a lack of data on bi+-specific stressors in existing alcohol-related IPV research, and (3) limited couple-level data from bi+ young adults despite IPV being a dyadic process impacted by both partners’ alcohol use and stress.
This study will address these gaps by examining potential intervention targets (i.e., bi+ specific stress, partner support) implicated by integrative alcohol-related IPV theories that exacerbate or mitigate IPV after drinking in the naturalistic settings of bi+ young adults and their partners. A rigorous, 60-day, daily diary approach will be used to collect daily reports of alcohol use, stress (e.g., bi+-specific stressors), partner support, and IPV perpetration/victimization from 50 bi+ young adults and their partners (N=100 individuals; 25 men/men or women/women couples, 25 men/women couples). Study aims are: (1) Determine if one’s own and one’s partner’s alcohol use increases IPV perpetration on days when bi+ individuals and their partners report high, but not low, levels of stress. (2) Determine if one’s own and one’s partner’s alcohol use increases IPV perpetration on days when individuals perceive their partners as providing low, rather than high, levels of partner support. (3) Across Aims 1 and 2, explore descriptive differences between (a) men/men, women/women, and men/women dyads, (b) couples in which only one partner is, rather than neither partner being, heterosexual, and (c) IPV types to identify priority populations for future research. Data generated from this study will provide the most comprehensive, theoretically-informed assessment of alcohol-related IPV among bi+ young adults and their partners to date. In doing so, these results will provide the foundation required for future research to develop alcohol-related IPV interventions effectively tailored to meet the needs of bi+ young adults.

Public health relevance
This project will be the first to prioritize the daily experiences of bisexual (bi+; i.e., individuals who are attracted to men and women) young adults and their partners when examining the proximal and prospective association between alcohol use and intimate partner violence (IPV) perpetration. In doing so, this study will enhance the scientific knowledge of alcohol use and IPV disparities among bi+ young adults and their partners – a population at high risk for heavy drinking and IPV – while addressing methodological limitations of existing alcohol-related IPV research that hinders the development of effective interventions. By identifying theoretically-informed daily experiences unique to bi+ young adults and their partners that potentiate (e.g., bi+ stress) or mitigate (e.g., partner support) alcohol-related IPV, results will provide critically-needed evidence of specific factors that should be targeted in alcohol-related IPV interventions for this priority population.